Innate Cells with Adaptive Specificity: Bond Kinetics of NK Cell Inhibitory Receptor Ly49C

ABSTRACT
Natural killer (NK) cells function as cytotoxic cells towards virally-infected and tumor cells. They are also
important producers of cytokines to orchestrate immune response. These functions are regulated through a
balance of activating and inhibitory receptor signals in the presence of stress- and self-signals. When virally
infected or malignant cells downregulate expression of MHC class I (MHC-I), inhibitory receptors on NK cells are
no longer engaged, inducing NK cell function. Despite the idea that NK cells are based on such innate recognition
mechanisms, NK cells demonstrate different target cellular lysis when presented with different peptides such as
SIINFEKL from ovalbumin (OVA) or RGYVYGQGL from Vesicular Stomatitis Virus (VSV) on MHC-I. This
differential effector function occurs in the complete absence of direct contacts between peptide and Ly49C and
the basis for this is unknown. The overall goal of the proposed work is to determine how Ly49C imparts these
different NK cell functions with a view to developing strategies to manipulate NK cells. Antigen-dependent NK
cell recognition via modulation of inhibitory receptor recognition is a paradigm shifting concept and may impart
NK cell trained immunity. The Ly49 (mouse) family of inhibitory receptors in mice have been well characterized
with Ly49C being the dominant player in NK cell inhibition and licensing. Ly49C binds to MHC-I H-2Kb to signal
self and prevent the breakdown in tolerance. Ly49C binds H-2Kb underneath the peptide-binding domain
alongside the α3 helix domain with no direct contacts to the H-2Kb loaded peptide. As an innate germline
encoded receptor, non-specific binding to the constant region of MHC-I would be consistent with the nature of
innate immunity. However, Ly49C-peptide-H-2Kb interaction results in different biological activity depending on
the peptide. This project is based on published and preliminary data showing: 1) no peptide-dependent structural
differences with peptides bound to H-2Kb or when the entire Ly49C-peptide-H-2Kb interacts; 2) mechanosensing
measures such as two dimensional bond lifetime under force can dictate differential cell responses and, 3) our
preliminary data demonstrating that mechanosensing properties of inhibitory receptor Ly49C and its interaction
with peptide-H-2Kb is different depending on the peptide. My working hypothesis is that the bond lifetime as it
occurs at the membrane allows Ly49C to distinguish different peptides loaded into MHC. I will test my working
hypothesis under the following 2 specific aims: Aim 1. Demonstrate that Ly49C bond lifetime with
peptide:MHC molecules is a key feature for NK cell function. Aim 2. To delineate critical amino acids of
peptide for Ly49C function. At the completion of the proposed work I expect to define how NK cell trained
immunity occurs in an antigen specific manner. This information could be used for rationally designed
engineering for the treatment of cancers that can be destroyed by NK cells or infectious diseases where peptide
priming of NK cells could lead to trained NK cells that could better fight infectious diseases.

Public health relevance
PROJECT NARRATIVE The goal of the proposed study is to define how NK cells act in an antigen-specific manner, a paradigm shift relative to their innate function and consistent with the idea of trained immunity. This project is important as it defines a mechanism of how trained immunity in NK cells is generated and will focus on how NK cell inhibitory Ly49C receptors interact with specifc MHC-I molecules. The proposed research is relevant to the mission of the NIH to seek fundamental knowledge about the nature of living systems and apply that to lengthen life and reduce illness by defining a mechanistic receptor interaction that could be harnessed to regulate immunity.